Dopamine Neurotransmission in Tourette Syndrome

DESCRIPTION (provided by applicant): The proposed study will use dynamic molecular imaging to examine a novel hypothesis concerning nature of dysregulated dopamine neurotransmission in Tourette's syndrome (TS). It is known for several years that the dopamine system is dysregulated in TS, but the nature of dysregulation remains unclear because of contradictory evidence. Thus, symptomatic relief following administration of dopamine antagonists suggests hyperactivity of the dopamine system but the hyperactivity is not consistently supported by the data on receptor density, precursor and transporter uptake. Some of these data even suggest hypoactive dopamine. To reconcile contradictory data we hypothesize that the tonic pool of dopamine is attenuated in TS. It leads to compensatory enhancement of the phasic release. Increased phasic release is known to impair processing of the central inhibitory system, which in turn impairs the ability to inhibit unwanted response in TS patients. Consistent with this hypothesis, studies that have directly or indirectly measured the tonic pool have found reduced dopamine activity while those that have studied the phasic release have reported increased activity in TS. In the proposed study the validity of hypothesis will be examined by detecting, mapping and measuring the tonic and phasic release of dopamine in TS patients and matched healthy control volunteers using a recently developed dynamic molecular imaging technique. The tonic pool in the striatal and extrastriatal areas will be estimated by estimating the binding potentials (BP) of dopamine receptor ligands 11C-raclopride and 18F-fallypride respectively at rest. Comparison of the data acquired in the two groups will indicate whether the tonic pool is reduced in TS. For measurement of the phasic release, changes in the rate of ligand displacement (from receptor sites) and the ligand BP will be estimated during performance of a task that requires inhibition of an unwanted response (Eriksen's flanker task). During the task performance concentration of previously administered dopamine receptor ligand (11C-raclopride or 18F-fallypride) will be dynamically measured using a positron emission tomography (PET) camera. This measurement will be applied to newly developed receptor kinetic models to estimate values of the receptor kinetic parameters before and after task initiation. These measurements will help us detect, map and measure dopamine released during task performance. Comparison of the data acquired in TS patients and healthy control volunteers will indicate whether the phasic release is enhanced during response inhibition in TS. The study will advance our understanding of the nature of dysregulated dopamine neurotransmission in TS and demonstrate that the dynamic molecular imaging can be used to study dysregulated dopamine neurotransmission in neuropsychiatric conditions. Additionally, data acquired in the proposed experiments can be used to develop novel therapeutic strategies and targets for treatment and prevention of cognitive deficits in TS.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed study will examine an important hypothesis concerning pathophysiology of Tourette syndrome, which is a disabling condition. The results will allow better understanding of neurocognitive deficits and could lead to development of novel therapeutic strategies and targets for treatment and prevention of cognitive deficits in Tourette's patients. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Converging evidence from clinical and experimental studies indicates that the dopaminergic system is dysregulated in Tourette syndrome (TS). The nature of dysregulation however, is unclear because of contradictory findings suggesting either increased or decreased dopaminergic activity. The observation that the antagonists of dopamine significantly reduce frequency of tics suggests that the dopaminergic system is hyperactive. However, data on receptor density, precursor uptake and dopamine transporter do not consistently indicate increased activity. Some of these data indicate hypoactive dopamine system. In addition, a growing number of reports suggest that not only antagonists but agonists of dopamine also improve tic frequency in TS. These observations led to contradictory conclusions concerning dopamine activity in TS. The contradiction could be due to two separate pools of the brain dopamine. In the brain dopamine is released tonically at rest (resulting in chronic accumulation in the extrasynaptic space) and phasically in response to a stimulus (additional dopamine released during task performance). It appears that most of the studies that suggest hyperactive dopamine system have used parameters that are dependent on the phasic release, and those suggesting hypoactivity have studied the tonic pool. It is therefore possible that in TS the tonic pool is reduced and there is compensatory enhancement of the phasic release. Since increased phasic release 'over- stimulates' and dysregulates the brain inhibitory and executive systems, it may be responsible for the symptoms that include inability to inhibit unwanted responses. We therefore hypothesize that dysregulation of dopamine neurotransmission in TS involves reduced tonic and increased phasic release. Since this hypothesis reconciles most of the contradictory findings, it is important to examine its validity. We propose to use a recently developed dynamic molecular imaging technique to examine validity of the hypothesis. Using this technique, the tonic pool will be measured in TS patients and matched healthy control volunteers by estimating binding potentials (BP) of dopamine receptor ligands. The ligand 11C-raclopride will be used to measure the striatal tonic pool and the pool outside the striatum will be measured using a high affinity ligand 18F-fallypride. Comparison of the data acquired in TS patients and healthy control volunteers will indicate whether the tonic pool is reduced in TS. It will also identify the brain areas where it is significantly altered. The phasic release of dopamine in TS and healthy control volunteers will be estimated by measuring dopamine released in the striatal (using 11C-raclopride) and extrastriatal areas (using 18F-fallypride) of the brain during performance of a task that activates the executive inhibitory system. Poor performance of TS patients in the task of executive inhibition (e.g. Eriksen's flanker task) suggests impaired processing of the brain inhibitory system. Study of the phasic release during task performance will indicate whether dysregulated phasic release is responsible for the impairment. The phasic release will be detected, mapped and measured in this study using recently developed receptor kinetic models and the dynamic molecular imaging technique. Our preliminary experiments show that this technique can be used to reliably detect, map, and measure dopamine released inside and outside the striatum during processing of inhibition in Eriksen's flanker task. The technique exploits the competition between dopamine and its ligand for receptor occupancy. Because of this competition dopamine released during task performance displaces previously administered radiolabeled ligand from receptor sites. Thus, the rate of ligand displacement increases if dopamine is released during task performance. We propose to measure values of a number of receptor kinetic parameters (including the rate of ligand displacement and ligand BP) before and after task performance. For these measurements the ligand concentration during task performance will be estimated dynamically using a positron emission tomography (PET) camera. The PET data will be analyzed using multiple receptor kinetic models to measure values of the receptor kinetic parameters. Using these values, dopamine released during processing of executive inhibition will be detected, mapped and measured in TS patients and healthy control volunteers. Comparison of the data acquired in the two groups will suggest whether the phasic release is enhanced in TS. The comparison will also locate the brain areas where the phasic release is altered in TS. Analysis of the relationship between task performance and the tonic and phasic release of dopamine will help us understand whether dysregulated dopamine neurotransmission is responsible for impaired processing of executive inhibition in TS. The specific aims of the study include: Specific Aim 1: To examine the hypothesis that phasic release of dopamine is enhanced in TS during processing of executive inhibition. We propose to conduct 4 experiments to examine the hypothesis. In Experiments 1-2 the phasic release in the striatum will be detected, mapped and measured in healthy control volunteers and TS patients during performance of a task of executive inhibition (Eriksen's flanker task). In Experiments 3-4 dopamine released outside the striatum will be studied in healthy control volunteers and TS patients during performance of Eriksen's flanker task. Specific Aim 2: To examine the hypothesis that tonic pool of dopamine is reduced in TS. We propose to conduct 4 experiments to examine this hypothesis. In Experiments 5-6, tonic pool of striatal dopamine will be mapped and measured in healthy control volunteers and TS patients. The tonic pool of extrastriatal dopamine will be studied in healthy control volunteers and TS patients in Experiments 7-8.